Novel mechanisms linking blood coagulation to liver fibrosis

Project Summary/Abstract
The overarching goal of this proposal is to develop the skills required to achieve my career goal of becoming an
independent investigator with a research focus on the role of blood coagulation factors in cell signaling during
tissue injury and inflammation. Accordingly, I have developed a Research Plan that will build a strong foundation
for conducting research across disciplines in hepatology, toxicology, and thrombosis and hemostasis. Strong
clinical and experimental evidence suggests that the blood coagulation cascade plays a pathologic role in the
progression of hepatic fibrosis, i.e., “scarring” of the chronically injured liver. One hypothesis linking coagulation
activity to hepatic fibrosis proposes that the coagulation protease thrombin drives hepatic stellate cells (HSCs)
to a collagen-expressing myofibroblast phenotype by activating its primary receptor, protease-activated receptor-
1 (PAR-1). However, the precise mechanisms linking PAR-1 activation to the HSC pro-fibrotic phenotype are
unknown. My central hypothesis is that thrombin activation of PAR-1 drives HSCs to a pro-fibrotic phenotype by
amplifying the signaling functions of tissue factor (TF), the transmembrane receptor for coagulation factor VIIa
(FVIIa). To test this hypothesis, I propose three Specific Aims. First, I will determine the mechanisms whereby
PAR-1 activation drives a pro-fibrotic phenotype in hepatic stellate cells. I hypothesize that PAR-1 activation
amplifies the HSC pro-fibrotic phenotype through induction of TF:FVIIa signaling. The role of TF:FVIIa signaling
in PAR-1-mediated HSC activation will be determined using a combination of in vitro approaches including
exogenous FVIIa treatment and HSCs lacking TF or PAR-2 (i.e., the receptor mediating TF:FVIIa signaling). The
role of HSC TF in experimental hepatic fibrosis will be determined using novel mice with HSC-specific TF
deficiency. Next, I will determine the role of thrombin:PAR-1 signaling in experimental hepatic fibrosis. The
precise role of thrombin-mediated PAR-1 activation in hepatic fibrosis has never been investigated in vivo
because PAR-1 can be cleaved by multiple proteases. I hypothesize that activation of PAR-1 by thrombin drives
experimental hepatic fibrosis. To test this hypothesis, I will use a combination of strategies including mice
expressing ~10% of normal prothrombin levels and novel mutant mice expressing PAR-1 that is selectively
insensitive to cleavage at specific residues by thrombin or by other agonist proteases. Finally, I will identify the
mechanisms driving coagulation activation in the injured liver. I hypothesize that coagulation activation in
experimental CCl4-induced chronic liver injury is driven by the intrinsic coagulation pathway. I will use
complementary genetic and pharmacologic approaches to determine the precise role of the extrinsic and intrinsic
pathways of coagulation cascade activation in hepatic fibrosis driven by experimental chronic liver injury. The
proposed studies will allow me to carve out a unique research niche investigating the cell signaling functions of
blood coagulation factors, and would ultimately drive development of novel therapeutics which target local
coagulation-mediated cell signaling events to reduce hepatic fibrosis with minimal impact on normal hemostasis.

Public health relevance
Project Narrative Chronic liver disease is a major contributor to morbidity and mortality worldwide, in part because there are no therapies to delay progression or promote resolution of hepatic fibrosis, the end stage pathology of chronic liver disease. Activation of the blood clotting cascade is associated with chronic liver disease progression, but the specific mechanisms linking clotting factors to deposition of scar tissue (i.e., collagen) in the injured liver are poorly understood. The primary goal of this research proposal is to uncover precisely how blood clotting factors interact with collagen-producing cells in the injured liver so that new therapies can be designed to delay the progression of liver fibrosis in patients.